Biologically-engineered Transcatheter Vein Valve: Design Optimization and Preclinical Testing

Project Summary
This research plan is aimed at creating an off-the-shelf transcatheter vein valve capable
of regeneration. If successful, it could treat many thousands of patients who suffer from chronic
venous insufficiency in deep veins, untreatable with compression stockings, and the sequelae of
debilitating leg ulcers, as there is currently no FDA-approved prosthetic vein valve. This novel
vein valve is created from a tissue grown from donor dermal fibroblasts directly on a nitinol stent
followed by decellularization. We have shown in a recent publication that the resulting bileaflet
valve meets hydrodynamic performance criteria in vitro and regenerates with host cells,
including endothelialization, without gross calcification, stenosis, or thickening of the leaflets
post-delivery in the ovine iliac vein model based on initial testing.
We propose here to make a key improvement upon the initial design and results by
using a stent that transitions from a circular section to an oval section, emulating vein valve
sinuses to improve hemodynamics and mitigate leaflet fusion to the valve wall that currently
occurs in vivo over time. In this milestone-driven plan, valve geometries will first be screened
using computational modeling of valve function and then characterized hydrodynamically.
Valves of 12 mm diameter enhanced with these sinuses will be delivered via catheter to the
ovine iliac vein for up to 24-week duration with (R61 phase) and without (R33 phase) sustained
anti-coagulation based on the rate of endothelialization. Delivery will be conducted in the normal
anatomy and in a venous reflux model in sheep achieved by compromising the tricuspid valve
sufficiently to ensure the valves are cycled in these quadrupeds. Longitudinal assessment of
valve function will be made via ultrasound and venogram. Harvested valve leaflets will be
assessed for dimensions, tensile mechanical properties, cellularity and phenotype via
immunohistochemistry, and matrix composition via biochemical assay and histology.
An INTERACT meeting will also be conducted during the R33 phase to ascertain GMP
manufacturing and GLP testing expectations of the FDA for a transcatheter vein valve,
extending prior FDA interaction regarding the decellularized tissue that we create in vitro to
include stent and valve testing in light of ISO standards that exist for transcatheter heart valves.
Our Office of Technology Commercialization will also be engaged regarding patent protection
beyond the PCT filed and commercialization opportunities.

Public health relevance
Project Narrative This research plan will design, fabricate, and test a replacement regenerative vein valve to treat patients with diseased valves that cause blood to pool in their legs. The valve is grown from a donor’s skin cells directly on a stent for minimally invasive delivery via a catheter and then decellularized for implantation into any patient without an immune response. Computer-aided design will be used to identify the optimal valve design, and after extensive bench-top testing, the valve will be tested in the iliac veins of sheep, then the FDA engaged regarding the clinical approval process.